NIAID - VRC - Pre-Clinical Assessment of monoclonal antibodies and other promising vaccines/agents

The VRC is dedicated to improving global human health through the rigorous pursuit of effective vaccines for human diseases. The NIAID mission and scope includes rapidly responding to infectious disease outbreaks through research, development and clinical testing of therapeutics and vaccines against diseases caused by pathogens that threaten public health such as, HIV, pandemic influenza, and emerging and re-emerging infectious diseases like Ebola, Zika, and Malaria.